Network and circuit dynamics supporting dopaminergic control of sudden insight learning

Project Summary
Learning about environmental stimuli that predict meaningful outcomes such as rewards is crucial for the survival
of an organism. Cue-reward learning has historically been described by the “learning curve”, which appears
gradual in group-averaged behavioral data from many animals. However, it was shown nearly two decades ago
that learning curves from individual animals are not as gradual, but instead display an abrupt appearance of
behavioral learning. Such abrupt learning has been described as reflecting a sudden insight into task structure.
Despite this demonstration, little work has focused on understanding the distributed brain networks that support
such sudden behavioral learning of cue-reward associations. Here, we focus on the network and single cell
changes that precede both conditioned behavioral responding and dopamine release in nucleus accumbens and
during cue-reward learning. While many studies focus on the role of cue evoked dopamine release in behavioral
responding, our approach is fundamentally different as it identifies signals upstream of dopaminergic learning
and/or behavioral responding. Based on theoretical models of reinforcement learning, we hypothesize that such
signals will be conveyed by brain regions that maintain a timeline of experience, thereby providing the template
from which cue-reward associations can be extracted by DA neurons to guide learning. Based on published and
preliminary data, we will test the hypothesis that a network spanning lateral entorhinal cortex (LEC), hippocampal
CA1, and orbitofrontal cortex (OFC) guide DA signaling during acquisition of cue-reward associations. To test
this hypothesis, we will use a combination of large-scale two-photon calcium imaging, high-density
electrophysiology with Neuropixels probes, dopamine sensor fiber photometry, behavior measurements and
circuit dissection approaches around abrupt cue-reward learning in individual mice. We will analyze the data
using a host of approaches to quantify latency of neural learning in each region and identify the causal flow of
information between the different regions. We will also analyze the nature of learned representations in neurons
that precede DA signaling, which will allow a distinction between theories of associative learning. Collectively,
this proposal aims to close a fundamental gap in our understanding of the neural mechanisms guiding insight
learning.

Public health relevance
Project Narrative This study will examine the circuits that mediate sudden insight learning and how they sculpt dopamine signals during learning. This work identifying brain circuits involved in reward learning will allow us to better understand mechanisms underlying diseases such as addiction.